The Imprinted Gene Network in the programming of Non-Alcoholic Fatty Liver Disease by early life cadmium exposure

PROJECT SUMMARY
The toxic metal cadmium (Cd) is one of the top ten chemicals of major public health concern identified by the
World Health Organization. Cd exerts toxic effects on the kidneys, respiratory and skeletal systems, and long-
term exposure is associated with metabolic, cardiovascular and behavioral disorders. We and others have
shown that exposure to Cd during early life can lead to disease in adulthood. One of these diseases is non-
alcoholic fatty liver disease (NAFLD), characterized by fat accumulation, inflammation and tissue damage in
the liver. NAFLD affects 30-40 % of the US adult population, and patients with NAFLD have a higher risk of
developing liver cancer. The broad, long-term objectives of this project are to understand the mechanisms that
link early life Cd exposure to NAFLD in adulthood, and to use this knowledge to develop strategies that can
prevent or reverse this disease. To this end, we have collected data from pregnant women and their children in
North Carolina and demonstrated that DNA isolated from newborn cord blood carries molecular `signatures' of
Cd exposure. We propose that these signatures play an important role in Cd-induced NAFLD. In the current
proposal, we will use mouse and cell culture models to test this hypothesis, and determine how events at the
molecular level lead to disease. We propose three specific aims: 1) determine whether the molecular
signatures associated with Cd that we observe in humans cause changes to the activity of a set of genes
called imprinted genes, which play important roles in liver metabolism; 2) understand how changes to imprinted
gene activity lead to NAFLD; and 3) determine whether Cd could cause NAFLD solely through influencing the
activity of these genes. We aim to demonstrate that imprinted genes play a central role in linking early life Cd
exposure to NAFLD in adulthood, thereby identifying potential markers of disease susceptibility and providing
opportunities for treatment prior to disease onset.

Public health relevance
PROJECT NARRATIVE Cadmium is a toxic metal that is a major public health concern, due to its ubiquity in the human environment. If successful, our work will show that exposure to cadmium during development causes non-alcoholic fatty liver disease in later life through activating a specific set of genes, identifying these genes as potential markers of disease susceptibility and novel targets for treatment. Given that NAFLD affects 30-40 % of the US adult population, and has been linked to metabolic impairments and a shorter lifespan, findings from our work have the potential to improve disease prediction and management for a large number of people.